Identifying Adolescents at High Risk of Neurocognitive Disorder: Development and Validation of a Composite Risk Index

Project Summary
More than 1 in 3 children from lower middle income countries (LMIC) are cognitively impaired and at risk of
neurocognitive disorder (ND) due to malnutrition, immune dysfunction, HIV, and poverty-associated parasitic
infections. All LMIC children – including HIV unexposed uninfected (HUU), are at risk of ND but HIV-infected
and HIV-exposed uninfected (HEU) are at elevated risk. Presently, there is no reliable approach to separate
these vulnerable children along the continuum of risk for new-onset/progressive ND. This problem prevents
risk-stratification, timely identification and targeting of at-risk children for ND remediation or prevention
interventions. This project solves these problems by defining and validating a composite risk index (CRI) that
integrates rigorously identified ND risk factors based on prior research to predict future new or progressive ND.
The risk factors include malnutrition, immune dysfunction and HIV status. These factors will be combined into
the CRI using modern machine learning methods and longitudinal data available from established cohort of
750 Ugandan children age 6 – 18 years (250 PHIV, 250 HEU and 250 HUU). For HEU and HIV-infected
children this index will be refined into CRI-HEU and CRI-HIV, respectively, to include applicable maternal ART,
child's viral genome, and cART factors.
Preliminary data from this cohort have demonstrated that cognitive indices vary significantly within the 12
months reassessment period. Additional preliminary data shows that despite HAART, chronic-HIV infection as
well as nutritional, immunologic, and viral genome factors are associated with deficits in executive function,
psychosocial adjustment, and quality of life. We now propose to follow this already established cohort every
12 months to collect additional data at 0, 12, 24 and 36 months to be used in defining and validating CRI. CRI
will be used to predict new-onset/progressive ND during follow-up. Specific aims include:
1. To develop a CRI by combining intake data on nutrition, immune parameters and HIV status and their
interactions and perform internal and external validation of CRI as predictor of ND at 12 months.
2. To further internally and externally validate CRI for “out-of-time-window” prediction from 24 to 36 months.
3. For HEU and HIV-infected children, to refine CRI into CRI-HEU and CRI-HIV, respectively, by including
type of maternal ART, viral genome parameters, current cART regimen/adherence (as applicable), and
their interactions.
Overall Impact: This project advances the science needed to ensure that all children survive and thrive
neurodevelopmentally whether HIV-infected, HEU, or HUU through establishment of predictive index for ND.
Modifiable factors that are found to be driving this index can become potential targets for novel therapeutic
strategies and behavioral interventions to mitigate the high burden of ND and/or HAND –if HIV infected.

Public health relevance
PROJECT NARRATIVE/RELEVANCE This project will define and validate a prognostic tool for proactively identifying children at elevated risk of neurocognitive disorder (ND) and/or HIV-associated neurocognitive disorder (HAND) in order to produce knowledge that informs targets for interventions to improve neurodevelopmental outcomes and minimize ND/HAND. For the first time, established multiple separate risk factors for impaired neurodevelopment will be integrated to define a composite risk index based on factors of malnutrition and immune dysregulation. The index will then be refined for HIV-infected and HIV exposed uninfected children by incorporating maternal ART and HIV-specific factors – complications of long-term antiretroviral therapy and HIV-virus genetic factors. 0925-0001/0002 (Rev. 08/12) Page 1 of 1 Continuation Format Page